Transcription Factor Discovery in the Opportunistic Pathogen Pseudomonas aeruginosa

Pseudomonas aeruginosa is a gram-negative, aerobic/facultatively anaerobic, rod-shaped bacterium that is commonly found in freshwater environments. However, P. aeruginosa can become an opportunistic pathogen, causing increased morbidity and mortality in immunocompromised hosts, burn victims, and cystic fibrosis patients. For example, more than two million people are infected by P. aeruginosa annually, resulting in almost 90,000 deaths. Notably, the environmental versatility of P. aeruginosa, its multiple mechanisms for providing antibiotic resistance, and its wide range of dynamic defenses (e.g., biofilm formation) render P. aeruginosa a most challenging organism to treat effectively, even in today’s hospital settings.
The genes responsible for P. aeruginosa virulence are regulated by a host of sequence-specific transcription factors. Unfortunately, our knowledge regarding their transcriptional regulatory networks and how they can be modulated is woefully incomplete. Our laboratory has developed an iterative selection method, Restriction Endonuclease Protection Selection and Amplification (REPSA), which has proven highly successful in identifying consensus DNA binding sequences and target gene promoters for various transcription factors in bacteria, such as Escherichia coli and Thermus thermophilus. We now propose using REPSA to identify the binding sites and genes regulated by the MerR-family of transcription factors in P. aeruginosa, which are thought to be involved in mediating responses to environmental stimuli, e.g., oxidative stress, heavy metals, and antibiotics, involved in pathogenesis. Ultimately, such studies will illuminate global regulatory networks in this important pathogen, thereby facilitating the development of novel anti-P. aeruginosa therapeutics.
Notably, per the goals of the SuRE award mechanism, this project will support the research activities of the PI, a former NIH grant recipient, and will enhance the training opportunities of undergraduate and master’s graduate students at a large, primarily undergraduate institution, a major focus for the PI. An award will allow the PI to continue a record of training students who have gone on to further biomedical education in graduate or professional schools and/or have pursued careers in STEM industries. It will also allow the PI to apply the skills honed through continuous NSF-funded basic research to questions of direct relevance for human health.
RE: 5R16GM154191-02 (PI: Van Dyke, Michael W.)

Public health relevance
Pseudomonas aeruginosa is the cause of most hospital-acquired infections, infecting more than two million people annually and resulting in almost 90,000 deaths. Notably, the environmental versatility of P. aeruginosa, its multiple mechanisms for antibiotic resistance, and its wide range of dynamic defenses (e.g., biofilm formation) render it a most challenging organism to treat effectively. Understanding the proteins that regulate these processes (e.g., transcription factors) will illuminate new pathways and targets for the development of anti-P. aeruginosa therapeutics.